Virus-host interactions regulating innate signaling for human cytomegalovirus latency

PROJECT SUMMARY
The goal of our research program is to elucidate molecular mechanisms by which HCMV regulates host
signaling in CD34+ hematopoietic progenitor cells (HPCs) for the establishment and maintenance of viral
latency and reactivation from latency. HCMV remains a significant cause of morbidity and mortality after solid
organ and hematopoietic stem cell transplantation despite advances in diagnostics and therapeutics. HCMV
latency is complex and the signaling mechanisms regulating the establishment and maintenance of HCMV
latency, as well as for reactivation of HCMV, are poorly understood. We have identified a locus of viral genes in
the ULb’ region of the genome that coordinates the expression of four genes, UL133, UL135, UL136, and
UL138, from polycistronic transcripts. Using state-of-the art in vitro models in human CD34+ HPCs and in vivo
models in humanized mice, we will define virus-host interactions modulating host signaling for the
establishment of latency. Our preliminary data show that the latency determinant, UL138, interacts with host
WD Repeat containing protein 48 (WDR48), which serves as a scaffold to activate ubiquitin specific protease,
USP1, USP12, and USP46. WDR48-USP1 complexes regulate STAT1 and AKT signaling and we demonstrate
that UL138 directs the activity of WDR48-USP1 to induce the activation of STAT1. We further show that USP1
activity it important for the establishment of a latent infection, such that when USP1 is inhibited, the virus
replicates in the absence of a replication stimulus. We hypothesize that UL138 interaction directs WDR48-USP
complexes to regulate innate signaling to suppress virus replication to prevent reactivation. In Aim 1, we will
determine how UL138 impacts WDR48/USP complexes and function. We will map the amino acids in UL138
that are required for interaction with WDR48/USP complexes and generate recombinant viruses defective for
these interactions. We will distinguish roles of the UL138-WDR48/USP1 interactions from that of UL138-EGFR
interactions. Further, we have shown that UL138 sustains AKT signaling, at least in part through an interaction
with EGFR, but interaction with USP12 and USP46 may provide additional avenues to the regulation of AKT.
Aim 2 will determine how UL138-WDR48/USP interactions impact latency and reactivation and the role of
UL138 in activating STAT1 and AKT using recombinant viruses and knockdown of host factors. This project
will provide the comprehensive and mechanistic insights into the multi-faceted regulation of host signaling for
the control of HCMV latency. The network of viral and host factors we have identified uniquely position us to
define novel host and viral targets for antiviral strategies to control HCMV latency or reactivation.

Public health relevance
PROJECT NARRATIVE The goal of our Program is to elucidate the molecular mechanisms by which human cytomegalovirus regulates molecular signaling in the host to establish latency and reactivate. Despite advances in diagnostics and therapeutics, HCMV remains a major life-threatening complication following solid organ or stem cell transplantation. Our projects will define a network of virus-host interactions that will inform antiviral strategies to control HCMV latency and reactivation.